Comparative Epigenomics of Primate Brains

Project Summary
Epigenetic modifications are essential chemical modifications that play critical roles in gene regulation,
development, and diseases. Therefore, understanding how epigenetic changes between species occur and
how they affect gene regulation has potential to advance our knowledge of regulatory evolution. However, the
details of epigenetic evolution are sparse, and how epigenetic evolution correlates with phenotype evolution is
even less understood. The proposed research will address this gap of knowledge by integrating novel data on
DNA methylation with primate brain evolution. Studies of human brains have demonstrated that distinctive
brain cell types have substantially different DNA methylation and gene expression, and analyses without
separating these cell types can yield misleading results. Additionally, comparative studies of primates and
other mammals have shown that the anatomical and cellular structure of brain regions evolve at varying rates
as a result of differences in neurodevelopmental events linked to overall brain size. DNA methylation is a key
molecular mechanism to record and affect development, and shows difference between brain regions.
Therefore, the proposed research will test a novel hypothesis that DNA methylation of distinctive cell types in
human and non-human primate brains shows variation consistent with brain size evolution. Moreover,
validation studies will be performed for specific candidate genes and genomic regions that show DNA
methylation and gene expression difference related to brain region differences and species differences.
Specifically, evolutionary histories will be constructed for DNA methylation (Specific Aim 1) and gene
expression (Specific Aim 2) from two major subclasses of neurons (excitatory and inhibitory neurons) as well
as oligodendrocytes (a major non-neuronal cell) of brains from diverse anthropoid primates, including humans,
apes, and monkeys. Highly divergent brain regions in terms of function and anatomy (e.g., prefrontal cortex
and the pons) will be compared to connect changes at the phenotypic level to molecular changes. Some of
these candidate genes will be further investigated in deeper histological resolution (Specific Aim 3). This study
will generate novel data to expand our understanding of epigenetic evolution of brains, and to infer functionally
important positions of noncoding genomic regions. Furthermore, it will also provide knowledge on how
epigenome changes during evolution and how epigenome evolution correlates with phenotype, which is a
fundamental yet currently little understood topic.

Public health relevance
PROJECT NARRATIVE Patterns of DNA methylation changes between species can be used to understand which regions of the genome are functionally important and relevant for diseases, yet are currently unknown. In this project, we will construct evolutionary histories of DNA methylation from three major cell types from two distinctive regions of human and non-human primate brains. This will help us determine how DNA methylation has changed during human brain evolution and how it underlies neuropsychiatric diseases. 1